ACTG 076--SAFETY &TOLERANCE OF ZDV FOR PREVENTION OF MATERNAL/FETAL HIV INFECTIO

This study is to determine if ZDV given to an HIV-infected pregnant woman as early as the first three months of pregnancy, and continued in her infant from birth to six weeks of age, will protect the baby from becoming infected with HIV.